Center for Suicide Research and Prevention - Administrative Core

The Administrative Core (AC) will provide overall support and integration of operations for the proposed Center
for Suicide Research and Prevention (CSRP). The CSRP aims to create a unique, interdisciplinary community
and platform for driving practice-based research on suicide prevention, bringing together leading experts,
emerging scholars and trainees, and key stakeholders to develop and implement novel approaches to suicide
prevention. The first specific aim of the AC will be to establish and provide the essential infrastructure and
governance to coordinate activities of the Methods Core (MC) and Center research projects. The AC will be led
by MPIs Jordan Smoller and Matthew Nock, who will also annually alternate chairing the Center Steering
Committee. Key Center activities will be driven by additional committees: Training, Pilot Grant Program,
Disseminations/Communications and Publications (each of which will include Stakeholder representatives.
The work of the AC will be guided by input from an External Advisory Board of leading experts and a
Stakeholder Panel reflecting the diverse perspectives of individuals with lived experience, healthcare
executives, public sector representatives, and community partners who will partner with the Center on
identifying and addressing unmet needs and shaping of ongoing research projects. The AC also will interface
with the Mass General Brigham (MGB) Systems Behavioral Mental Health Committee to ensure
implementation of a learning health system for suicide prevention across the MGB system. AC co-investigators
include senior leaders in psychiatric research, suicide prevention, implementation science and bioethics and
regulatory issuesdrawn from the MGB healthcare system, Harvard University Faculty of Arts and Sciences,
Harvard Medical School, and the Harvard T.H. Chan School of Public Health. Second, the AC will establish
and implement programs to support novel pilot research and an expansion of the workforce devoted to
practice-based suicide research. This will include a Pilot Grant Program to evaluate and fund promising new
directions in suicide research as well as a Collaborating Scholars Program to engage emerging and advanced
career investigators in multidisciplinary research relevant to suicide prevention, with a focus on recruiting
individuals from groups traditionally underrepresented in medicine. Third, the AC will develop tools and
platforms to disseminate evidence-based suicide prevention research and promote outreach to relevant
community partners. This will include the development of the CSRP website, a biannual newsletter, a monthly
all-hands CSRP meeting, and monthly CSRP-sponsored speakers’ series. We also will organize an annual
conference toprovide a national forum for highlighting emerging research related to suicide prevention. Fourth,
in conjunction with the MC and guidance from the CSRP Program Evaluation and Planning Committee, we will
establish and implement a program evaluation plan to allow iterative refinement of the Center's ongoing
activities and inform plans for future growth of the CSRP and collaborative research.